Adenosine receptor mediated therapies for SUDEP

Project Summary/Abstract
Sudden unexpected death in epilepsy (SUDEP) remains a major concern for persons with epilepsy and their
families. The incidence of SUDEP is estimated at 1 to 2.5 per 1000 patient years however the underlying
reasons are poorly understood. Here we will address the adenosine hypothesis of SUDEP. Epileptic seizures
trigger a surge of adenosine (ADO), which is an endogenous agent required for seizure termination, but which
also controls respiratory functions in the brainstem by activation of different subtypes of adenosine receptors
(ARs). Our overarching hypothesis is that a seizure-induced increase in ADO in combination with insufficient
metabolic clearance of ADO in the brainstem can cause fatal over-activation of ARs leading to brainstem
dysregulation and respiratory dysfunction as a precipitator of SUDEP. In support of our hypothesis, we
demonstrated that a non-selective AR antagonist (caffeine) reduced lethal apnea in rodent models of
epilepsy and traumatic brain injury. Our preliminary data support a strong association between ADO
metabolism, AR activation, and lethal apnea. For those reasons we focus our proposal on the brainstem-
dependent respiratory mechanisms of SUDEP.
Specifically, we will address our central hypothesis that the susceptibility to SUDEP is related to
abnormal ADO metabolism and signaling in respiratory regions of the brainstem and preventable by
therapeutic interventions that enhance metabolic clearance of ADO or block AR activation. Brainstem
specific manipulations will allow us to test a specific role of ADO in the brainstem. Dissection of seizure-related
functions of ADO metabolism and signaling in the limbic system from respiratory control functions in the
brainstem will enable a translational path for ADO-manipulation for the prevention of SUDEP. Our model
system is a `SUDEP-prone mouse' with impaired metabolic clearance of ADO due to a heterozygous disruption
of the adenosine kinase (Adk) gene. ADK, expressed in astrocytes is the main metabolic clearance route for
ADO in the brain. Our research goals will be approached in 3 Specific Aims: (1) Test hypothesis that SUDEP is
associated with maladaptive changes in ADO metabolism. (2) Test hypothesis that caffeine plays a critical role
in SUDEP susceptibility. (3) Test whether suppression of A2AR activation can prevent SUDEP. The expected
outcome of this research is the demonstration that the capacity for the metabolic clearance of seizure-induced
ADO through the brainstem determines susceptibility to SUDEP. Mechanistic studies will identify the AR
subtypes involved. In addition, this research will help to clarify whether the chronic use of caffeine is of benefit
or presents a risk factor for persons with epilepsy. Finally, we will test whether A2AR antagonists, which are
already in clinical development for the treatment of Parkinson's disease, can prevent SUDEP.

Public health relevance
Project Narrative Adenosine is a metabolic regulator of important physiological functions such as brain activity and respiration. We propose that maladaptive changes in adenosine metabolism and signaling contribute to sudden unexpected death in epilepsy (SUDEP). We will investigate underlying mechanisms in a novel SUDEP prone mouse model and will translate those findings into therapeutic strategies and recommendations for the prevention of SUDEP, which are based on reconstituting metabolic clearance of adenosine and blocking adenosine receptors through agents such as caffeine.